Brain Injury Knowledge Ontology (BIKO): Identifying Metadata Variance in Traumatic Brain Injury Therapy Studies

Project Summary
Traumatic brain injury is a significant cause of morbidity and mortality in the United States, yet there is no
approved therapy for this injury. Although several therapies and procedures have been deemed successful for
TBI treatment in preclinical research studies, many of these successes did not translate to human studies. One
way to examine this challenge is to investigate the methodological variances in the associated literature. This
proposal aims to use experimental methods and outcomes used in traumatic brain injury (TBI) therapy papers
to create a metric to compare the methodological variance between multiple species by following three aims: 1.
Training Phase 1: Establish the Brain Injury Knowledge Ontology (BIKO), a standardized ontology to define
experimental design parameters and outcomes. 2. Training Phase 1: Create a knowledge base, BIKO base, of
experimental design parameters (methods) and scientific claims (results) from the TBI treatment discovery
literature. 3. Training Phase 2: Compare experimental differences hypothesized to lead to distinct outcomes
between and across multiple species in TBI studies/literature using the BIKO. Upon completion, this project will
provide a clearer understanding of past preclinical TBI therapy success and how it aligns to clinical outcomes to
accelerate the discovery of successful therapies for TBI in human patients.

Public health relevance
Project Narrative Traumatic brain injury (TBI) is a major cause of morbidity and mortality in the United States. Although several studies have found successful therapies for TBI in preclinical studies, success has not translated to clinical studies. The goal of this project is to use text mining of the TBI literature to compare the methodological variance between published studies. to determine whether differences in methods across studies can explain why some studies fail. This measure will assist in closing the knowledge gap between preclinical and clinical therapeutic studies.